Mechanisms of neuronal TRPM2 channel effects on Post-Stroke Cognitive Impairment

Abstract / Project Summary
Stroke is a significant contributor to death and disability worldwide. With increased survivability due to
advancements in clinical treatments, 35-50% of patients suffer from long-term neurological deficits in learning
and memory termed Post-Stroke Cognitive Impairment (PSCI). Utilizing the middle cerebral artery occlusion
(MCAO) model of focal ischemia, we can investigate chronic timepoints post-stroke to ameliorate cognitive
deficits. Our lab has targeted the transient receptor potential melastatin 2 (TRPM2) channel as a potential locus
of therapeutics. As a Ca2+ permeable non-specific cation channel, TRPM2 is activated in periods of oxidative
stress, such as in stroke, and contributes to both cognitive and synaptic dysfunction. Indeed, data obtained in
the laboratory before I joined demonstrates that acute and delayed administration of a TRPM2 channel
antagonist improves synaptic and cognitive recovery following experimental stroke. TRPM2 is in multiple cell-
types throughout the brain, and I seek to investigate the neuronal component of TRPM2 by utilizing genetic
animal models and adeno-associated viruses (AAVs) to conditionally knockout TRPM2 from neurons. In aim 1,
I hypothesize that a neuron-specific knockout rescues long-term potentiation (LTP) and behavioral deficits up
to 30-days post-stroke. In aim 2, I seek to investigate the downstream mediators of TRPM2. Data suggests that
in periods of hypoxia, a positive feedback loop is initiated; TRPM2 is activated and the kinase PKC is then
recruited to the area where it phosphorylates TRPM2 at serine 38 further enhancing activation of the TRPM2
channel. Calcineurin activates (dephosphorylates) glycogen synthase kinase 3-beta (GSK-3) after TRPM2
activation. Evidence shows that dephosphorylated GSK-3 is responsible for the internalization of a-amino-3-
hydroxy-5-methyl-4-isoxazolepropionate (AMPA) receptors ultimately leading to a decrease in LTP. A final player
in this complex signaling pathway is regulator of calcineurin 1 (RCAN1), which binds to calcineurin and increases
its activity at key phosphorylation sites. Due to RCAN1’s role within the calcineurin-GSK-3β signaling pathway,
RCAN1 is implicated in the bidirectional regulation of hippocampal synaptic plasticity. Data further suggests a
potential link between PKC and the downstream actions of RCAN1 are mediated by TRPM2 channel activation.
In aim 2, I hypothesize that decreasing RCAN1 and GSK-3 expression will rescue LTP deficits. This training
plan will build methodological skills in electrophysiology, biochemical analyses, and more culminating in multiple
manuscripts. It will also foster the growth of my career attending seminars focused on women in STEM,
networking to further the advancement of women throughout academia, and mentoring the next generation of
scientists. I have chosen Dr. Paco Herson as my mentor at The Ohio State University because they maintain
incredibly high standards in state-of-the-art facilities that will ensure my development as an academic
neuroscientist.

Public health relevance
Project Narrative Stroke is leading cause of death and disability in the United States with approximately 795,000 patients each year. There have been significant advancements in the treatments of stroke that have led to an increase in survivability, yet 35-50% of the surviving population suffers from Post-Stroke Cognitive Impairments. The proposed studies will study potential therapeutic targets to rescue cognitive deficits enhancing the quality of life at a faster pace for hundreds of thousands of patients.